Comparative Medicine and Translational Research Training Program

7. CMTRTP ABSTRACT
The National Research Council has documented a dire national need for veterinary specialists
trained in biomedical research. Furthermore, veterinary researchers play a key role in
comparative and translational research activities since they naturally bridge basic and clinical
research. To address this training need, we request continued NIH funding for 7 fellows per year
for 3 years. NC State University will provide funding for up to 2 fellows per year and 2 pre-T32
positions. Trainees will be degree-seeking fellows in the Comparative Medicine and Translational
Research training program established by the faculty in the College of Veterinary Medicine (CVM)
and the Comparative Medicine Institute (CMI) at North Carolina State University. This training
program specifically targets individuals with the DVM degree who have completed specialty
training and is designed to prepare trainees to compete for an early career development award
and a rapid transition to independence as a principal investigator or in another research-intensive
career. Trainees complete requirements leading to the PhD degree in Comparative Biomedical
Sciences (CBS) in one of 7 areas of concentration: 1) Immunology 2) Cell Biology, 3)
Pharmacology, 4) Neurosciences, 5) Infectious Diseases, 6) Population Medicine and Global
Health, and 7) Pathology. Training faculty are well-funded productive scientists that have a strong
training track-record and diverse research expertise. Training faculty are all members of the CBS
graduate program and the CMI and represent 5 departments from 3 Colleges. Research projects
emphasize comparative and translational themes fostered by the CVM and CMI in functional
tissue engineering, translational pharmacology and physiology, and emerging and infectious
diseases. Program requirements include: (1) a capstone comparative animal models course; (2)
professional development courses and workshops; (3) courses in research ethics and research
rigor and reproducibility; (4) a grant writing course and (5) annual research symposia. These
requirements are in addition to those associated with the graduate program. Twenty four fellows
have completed training. Twenty hold faculty positions in academia, one is a research pathologist,
one is a clinical pathologist in industry, and one is a postdoctoral fellow. Fellows were awarded
18 NIH or other federal grants as PI and more than 50 extramural research grants and published
125 papers (84 first author) arising from their research while in training.

Public health relevance
8. NARRATIVE The NC State training program in Comparative Medicine and Translational Research addresses two critical national needs in biomedical research. First is the growing need for veterinarians with training in biomedical research. Second is that more emphasis needs to be placed on translation of basic research advances to the clinical setting and this often requires a multidisciplinary approach.